Investigating the role of the membrane in particulate methane monooxygenase (pMMO) structure and function

ABSTRACT
The atmospheric content of greenhouse gases, such as methane, has long been ruled by microbes, such
as methanotrophs. Recent human activity has upset this homeostasis, presenting an appreciable risk to human
health in the present and future. Particulate methane monooxygenase (pMMO), a copper-dependent
transmembrane enzyme from methanotrophic bacteria, oxidizes methane to methanol. Its ability to perform this
difficult chemical reaction at ambient temperature and pressure offers a window into developing processes for
conversion of biological natural gas to liquid (Bio-GTL) for climate change mitigation. Isolation of pMMO from the
membranes and detergent solubilization have hindered past studies, resulting in a loss of enzymatic activity and
distortion of protein structure. The failure of detergent micelles to recapitulate the physicochemical properties of
the membrane may perturb functionally important metal centers, protein-lipid interactions, and protein-protein
interactions. These challenges can be overcome by reconstituting pMMO in membrane mimetics like membrane
scaffold protein (MSP) nanodiscs (NDs) and bicelles using homogeneous synthetic lipid bilayers, which enable
partial recovery of pMMO activity and structure. The goal of this project is to explore the role of the native
membrane in pMMO structure and function. Aim 1 is to optimize pMMO activity in detergent-free native ND
systems. Preliminary data show that it is possible to reconstitute pMMO activity in NDs using native lipids
extracted from methanotrophs. These native lipid NDs exhibit activity comparable to or better than pMMO in
synthetic lipid NDs. Aim 2 is to characterize the membrane environment and its interaction with pMMO.
This information will be used to optimize membrane mimetics for delineating the effects of lipid environment on
pMMO structure and function. Untargeted and targeted lipidomics via mass spectrometry will be used to catalog
the major lipid classes and identify specific lipid species, while also determining their relative abundances in
native lipid extracts and membrane mimetics. Native mass spectrometry will provide insight into specific protein-
lipid interactions that occur within membrane mimetics, informing the modeling of these interactions in cryoEM
and crystal structures. Aim 3 is to characterize the structural effects of membrane mimetic environments
on pMMO. More native-like membrane mimetics may allow for determination of a more biologically relevant
pMMO structure by cryogenic electron microscopy (cryoEM). These studies will provide insight into the
importance of the membrane for pMMO function, including crucial details about the pMMO structure, copper
centers, transmembrane loops, protein-lipid interactions, protein-protein interactions, physiological reductant,
active site, and mechanism. This project may also provide generalizable information about the importance of the
native membrane environment for studying membrane proteins.

Public health relevance
PROJECT NARRATIVE Methane is a potent greenhouse gas that drives climate change and represents an appreciable burden on human and environmental health. A promising route toward mitigating climate change exists in the particulate methane monooxygenase (pMMO), a copper-dependent transmembrane enzyme from methanotrophic bacteria that oxidizes methane to methanol, a desirable biofuel. This project involves the use of innovative membrane mimetics to render pMMO more amenable for study, addressing longstanding questions about this important enzyme and membrane proteins in general, which are underrepresented in structural studies and fundamentally important in human health.